BDCRC - Administrative Core

ADMINISTRATIVE CORE – PROJECT SUMMARY/ABSTRACT
The Batten Disease Clinical Research Consortium (BDCRC) Administrative Core will serve as the organizational
center of the BDCRC, providing leadership, support, and coordination of the Cores and Research Projects. It will
serve as the primary liaison between patient advocacy groups, industry, the general public, and all activities of
the BDCRC. The Administrative Core will also be the liaison between the BDCRC, Data Management and
Coordinating Center (DMCC), and Rare Diseases Clinical Research Network (RDCRN) Consortia.
The Administrative Core will support efficient, high quality, and integrated consortium activities, and will ensure
optimal operational functioning of the Cores and Projects and contributions to the RDCRN. The Administrative
Core aims are to: 1) provide overarching operational support oversight of Cores and Projects, 2) manage
institutional and financial agreements and support research compliance, 3) integrate biostatistics and
bioinformatics expertise into Cores and Projects, 4) establish a national NCL biorepository, 5) coordinate effective
and timely communication among BDCRC sites, advocacy partners, affected families, the RDCRN, and other
Batten disease stakeholders to promote collaboration and dissemination of information.
Successful execution of the BDCRC Administrative Core aims will facilitate achievement of BDCRC Core and
Research Project aims. In turn, this will promote advancements in clinical trial readiness and future pre-clinical
discovery into novel therapies for individuals affected by the NCLs. The BDCRC Administrative Core aims will
also promote the broader mission of the RDCRN through active collaboration with RDCRN sub-groups and other
Consortia.